Trivalent Live Attenuated Vaccines for Bacterial Acute Otitis Media

Summary
Clinically, AOM is the leading reason for pediatrician visits and antibiotic usage by children. The
predominant causative agents of AOM are Streptococcus pneumoniae, Haemophilus
influenzae, and Moraxella catarrhalis. While currently licensed capsule-based vaccines have
dramatically lowered in the incidence of invasive pneumococcal disease, the incidence of
mucosal infections such as AOM has remained relatively unchanged. Likewise, non-typeable H.
influenzae currently predominates the AOM landscape following introduction of the Hib vaccine.
Additionally complicating matters is the potential concern that a vaccine targeting an individual
otopathogen may not reduce overall incidence of AOM due to the non-targeted pathogens
becoming more predominant following the removal of an individual pathogen. We have
engineered a safe, effective, and highly manipulatable platform for delivering protein epitopes to
the mucosal surface to target multiple otopathogens simultaneously while engendering
protective immunity at the mucosal surface. Leveraging a combinatorial approach for eliminating
multiple AOM pathogen simultaneously using a live vaccine platform to maximize mucosal
antibody responses represents a novel strategy for reducing the burden of AOM in children.

Public health relevance
Narrative An unmet clinical need for the prevention of acute otitis media is a vaccine that can target multiple otopathogens simultaneously in a strain independent manner while engendering protective immunity at the mucosal surface. We have addressed this via the generation of a novel, recombinant live attenuated vaccine strain platform that can be modified to express protective epitopes from multiple bacterial species to confer protective mucosal immunity. We plan to utilize this platform to explore the protective capacity and correlates of protections for a trivalent otitis media vaccine targeting Streptococcus pneumoniae, Haemophilus influenzae, and Moraxella catarrhalis.